Effects of sex chromosome constitution on global gene expression

PROJECT SUMMARY/ABSTRACT Males and females have striking differences in development, health and disease, but the underlying mechanisms remain poorly understood. At the genetic level, different sex chromosome constitutions, XX in females and XY in males, result in differential expression of sex chromosome genes. Autosomal genes are also differentially expressed between the sexes, but, since autosomal DNA content does not vary by sex, this difference is evidently due to epigenetics. Interestingly, sex chromosome genes encode transcription factors and chromatin modifiers, which may have different expression levels and/or activities in males and females. Thus, I hypothesize that the actions of epigenetic and transcriptional regulators encoded by the X and Y chromosomes create sexually dimorphic expression across the genome. In Aim 1, I will ascertain whether epigenetic and transcriptional programs depend on sex chromosome dosage using cells from males and females varying in their sex chromosome complement (XO, XX, XY, XXY, XYY, and XXX). In Aim 2, I will assess activities of candidate regulatory genes on the sex chromosomes in males and females, and individually manipulate them to investigate their functional roles in epigenetic and transcriptional sex differences. This work will increase our mechanistic understanding of differences between the sexes, and motivate future research on sex-biased diseases.

Public health relevance
PROJECT NARRATIVE Males and females differ in sex chromosome content, however not much is known about how this difference may influence cellular properties and explain sex differences observed in human development, health, and disease. The goal of this proposal is to evaluate whether genes on the sex chromosomes affect global gene expression. The results from these studies will identify candidate genes on the sex chromosomes responsible for sex differences, and identify autosomal gene modules they control, which have relevance for understanding phenotypes of males, females and individuals with abnormal numbers of sex chromosomes.